Personal and panel references for improved alignment

PROJECT SUMMARY
Next-generation sequencing is ubiquitous in the study of biology and disease. Analyzing a sequencing
dataset involves taking DNA fragments and determining where each originated with respect to a reference
genome, or with respect to a large collection of sequences like a pangenomic or taxonomic database.
These databases are growing rapidly, thanks to increasing availability of high-quality genome assemblies.
But this creates a tension: on the one had, our analyses should take full advantage of these sequences
to maximize sensitivity and avoid reference bias. On the other, our standard algorithms and methods do
not scale well to larger collections, necessitating larger computers, and more time and effort.
We propose a four-aim project to greatly improve the scalability of our day-to-day sequencing data
analysis tools. We build on the successful foundation of compressed full-text indexes: data structures that
facilitate efficient classification and alignment of sequences, but whose size grows the amount of distinct
sequence in the collection, i.e. the collection's compressed size rather than its raw size. A successful
project will enable a future where (a) sequencing-based diagnostics and therapeutics are free from reference
bias, (b) genomics algorithms run in time and space proportional to the data's compressed size
rather than its raw size, (c) continued sequence database growth poses no major hurdle to research, because
our methods eliminate redundancy and are not limited to particular k-mer lengths. All software and
training materials will be available under an open source license, per our team's track record.

Public health relevance
PROJECT NARRATIVE Many researchers use DNA sequencing to study disease and biology, and analyzing this data requires sophisticated software capable of piecing together puzzles made of billions of fragments of DNA. The main strategy used to assemble the puzzle - aligning sequencing reads to a genome - suffers from "reference bias" which can cause it to give incorrect answers. We will develop new methods that use a combination of compression, text indexing, and other ideas from computer science, to help researchers to analyze sequencing data while avoiding the perils of reference bias.